Research Training in Cardiovascular Biology at Meharry

DESCRIPTION (provided by applicant): This is the fourth renewal of a NHLBI supported Minority Institutional Research Training Program in cardiovascular biology at Meharry Medical College (MMC) that will focus in the considerable strengths and diversity of multidepartmental research in cardiovascular biology at MMC and Vanderbilt University School of Medicine (VUMC) into a unique and coherent framework for specialized training. The proposed program will support six pre-doctoral trainees per year and will involve 30 faculty members at MMC and VUMC. Three graduate programs at MMC and four departments at VUMC will participate in the program. The research training will focus on cardiovascular biology using cutting edge science and approaches to elucidate mechanisms causing cardiovascular as well as hematologic diseases. The Program Director, Dr. Fernando Villalta, will provide overall direction for the program and will be assisted by the co-Program Director, Dr. Z. Guo, a Professor of Physiology and Director of the Division of Cardiovascular Biology. The PD and co-PD will be assisted by oversight committees such as the Senior Oversight Committee (with MMC and VUMC faculty), the Faculty Advisory Committee (with MMC and VUMC faculty), the Student Advisory Committee and the External Advisory Committee. Program students will have a MMC advisor and a VUMC mentor from the core faculty who have common research interests in cardiovascular biology and will collaborate in the development of the student research plan together with the trainee. Each trainee will take a didactic course at VUMC and participate in research opportunities at the VUM mentor's lab. All trainees and faculty in the program will participate in a seminar series that include presentations by program participants and visiting scientists. The trainees will also participate in work in progress seminars and journal clubs in vascular biology. The goals of the program are to attract talented African-American and other minority students in their developmental stages, increase their awareness of cardiovascular diseases, and to encourage them to pursue career opportunities in research related to the mission of the NHLBI. These goals will be enhanced by the increasing number of collaborative research and training opportunities at MMC and VUMC resulting from the Meharry-Vanderbilt Alliance. (End of Abstract)

Public health relevance
This Cardiovascular Biology training program at Meharry in collaboration with Vanderbilt will attract talented African-American and other minority students in their developmental stages, increase their awareness of cardiovascular research, and encourage them to pursue NHLBI-mission relevant research career opportunities. This program will train a new generation of minority scientists in cardiovascular and hematologic diseases who will address the national ethnic under representation in Biomedical research.